A Novel Mouse Model for Spontaneous and Age-Related Choroidal Neovascularization

Abstract
Choroidal capillaries are normally kept behind the retina by the retinal pigment epithelium (RPE), a monolayer
of cells located between the retinal parenchyma and choroidal plexus. In humans, RPE integrity may
deteriorate with aging, especially in a small central area of the retina known as the macula. As a result, the
normally avascular photoreceptor tissue may become invaded by leaky choroidal capillaries through choroidal
neovascularization (CNV), which is a hallmark of the wet form of age-related macular degeneration (AMD) and
a leading cause of blindness among the senior population. Despite the short-term benefits of anti-VEGF
therapy, there is still no effective long-term treatment. To promote the development of novel therapies with
long-term benefits, we propose to create a chronic CNV model in which CNV occurs due to a set of
pathophysiological conditions mimicking those associated with wet AMD, including genetic susceptibility,
stressful environment, and aging. We will refer to the novel mouse model as age-related CNV (ArCNV),
following the style of “age-related macular degeneration”, although aging is not the only trigger in both cases.
In preliminary studies, genetic susceptibility was introduced into mice by the knockin of a Cre-dependent
transgene that is designed to knock down 5 specific mRNA targets (through the expression of 5 siRNAs) and
overexpress two proteins. The candidate genes were selected because their human homologs are associated
with increased risk of wet AMD. To simulate environmental risks, we designed a novel treatment regime
consisting of oxidative diet, smoking product, and light (oxDSL). When carried out separately, Cre-activation of
the transgene or treatment of wild-type C57BL/6J mice with oxDSL alone led to pre-CNV phenotypes such as
RPE degeneration, but not outright CNV. In combination, however, global transgene activation and treatment
with oxDSL led to CNV by 7 months of age, but not at much younger ages. Thus, the ArCNV model is age-
dependent. On other hand, the occurrence of CNV at the relatively early phase of aging will accelerate
research progress. In proposed studies, we will systematically characterize CNV onset and progression, along
with related phenotypes and molecular changes (Aim 1). Given the central role of the RPE barrier, we will also
activate the transgene with RPE-specific Cre and investigate whether such mice will develop CNV when
treated with the oxDSL regime (Aim 2). At the completion of this project, we will have systematically
characterized this novel mouse model, thus providing a highly valuable tool to the CNV research community.

Public health relevance
Narratives Age-related macular degeneration (AMD) is a leading cause of blindness at ages > 50. The objective of this project is to establish a novel mouse model that integrates multiple environmental and genetic factors suspected to contribute to AMD in human patients. The availability of such a model may greatly enhance our knowledge of AMD pathology and facilitate the development of novel AMD therapies.